Developmental Research Program (DRP)

PROJECT SUMMARY/ABSTRACT – DEVELOPMENTAL RESEARCH PROGRAM – (DRP)
The fundamental objective of the Developing Research Program (DRP) proposed in this SPORE application, is
to identify and recruit exceptional translational investigators to the field of prostate cancer (PCa) research. To
support these efforts, the DRP will provide short-term project support for innovative PCa research proposals with
a focus on science that has translational potential. Co-Led by Drs. Fujimori and Ashworth, accomplished
translational investigators whose academic career stages represent mid- and senior levels, the DRP will oversee
an annual intramural funded award program to support pilot research in prostate cancer. The DRP was
developed in the context of the broader activities of the UCSF Helen Diller Family Comprehensive Cancer Center
(HDFCCC). This organizational structure enhances SPORE functionality and productivity by leveraging
preexisting resources and collaborative mechanisms for petitioning and funding project awards. Responsibilities
of the DRP will include: 1) solicitation of applications; 2) review and critical assessment of each proposed project;
3) selection of DRP projects for funding; 4) review and assessment of DRP progress reports; and 5) evaluation
of projects, both for suitability of a second year of DRP funding, and potential for advancement to full SPORE
project status. The SPORE EAB, comprised by leaders in the field, will participate in the annual review of funded
projects, and will be involved in the process by which a DRP project is selected to replace a SPORE project. The
DRP, as an essential component of a SPORE, will be maintained throughout the entire life of the program and
will ensure quality developmental projects are available to replace projects and advance overall translational
research goals of the UCSF Prostate Cancer SPORE.